Identifying molecular markers of neuronal inhibition after opioids

Project summary/abstract
Immediate Early Genes (IEGs) are commonly used as proxy markers for neuronal activity in the context
of substance abuse research. Despite a wide-ranging catalog of activity-dependent IEGs, there is a notable
absence of genetically encoded markers of neuronal inactivity. This paucity is particularly noticeable in the
context of substances which principally exert inhibitory effects on target neuronal function, including opioids.
There is, therefore, a critical need to determine the transcripts that are upregulated following strong neuronal
inhibition. The overall objective in this application is to identify and characterize markers of inhibition within
neurons in the nucleus accumbens. Our central hypothesis is that distinct inhibited neurons will undergo
transcriptional changes that can be used to identify and one day manipulate these inhibited neurons. The
rationale for the proposed research is that understanding how neurons respond to inhibition will provide new
opportunities for developing experimental therapeutics to treating opioid use disorder. To attain the overall
objectives, the following specific aims will be pursued: 1) Identification of Immediate Early Genes expressed
following pharmacological inhibition of the nucleus accumbens (NAc); and 2) Identification of Immediate Early
Genes expressed following pharmacological inhibition with fentanyl. The research proposed in this application
is innovative because it applies cutting edge methods to identify immediate early genes that are expressed in
inhibited neurons for the first time. These contributions will have significant impact because they are expected
to build a foundation for unprecedented analysis of patterns of excitatory and inhibitory activity throughout the
brain.

Public health relevance
Project Narrative This proposal will use advanced molecular techniques to identify specific genes expressed in neurons when they are inhibited by opioids, rather than when they are active - which is a common focus in current research. This shift in perspective is crucial for understanding the full spectrum of brain activity, especially in the context of substance abuse, where drugs often exert their effects by inhibiting certain neurons.